GILA RIVER INDIAN COMMUNITY AUTOPSY STUDY

The postmortem characteristics of Pima Indians of the Gila River Indian Community are investigated so that findings in subjects with and without diabetes mellitus can be correlated with studies in living subjects.